Molecular Basis of Hypoxia-Induced Excessive Erythrocytosis

Project Summary/Abstract
Up to twenty percent of individuals living at high altitude in the Peruvian mountains and, to a lesser
degree in Tibet, suffer from Monge's disease or Chronic Mountain Sickness (CMS). These subjects die in early
adulthood because of excessive erythrocytosis (Polycythemia, hematocrit>60%). It is estimated that there are
over 100 million people who live at altitudes > 2500 m world-wide, who are at risk for CMS. We are particularly
interested in patients with CMS because they constitute a unique population that allows us to study how
mechanisms of erythropoiesis can become awry or get exaggerated based on environmental conditions. The
uniqueness of this population is even more significant when we realize that there are subjects that live side by
side at similar altitudes as those with CMS but do not suffer from this disease.
We have already demonstrated through whole genome sequencing that there are several genome-wide
regions (containing a number of genes) that are consistent with selective sweeps in Peruvian subjects with
polycythemia. Further, with the use of skin biopsies and native blood cells from CMS and non-CMS subjects,
we have obtained iPS cells and differentiated them into red blood cells. We will use in this application the
results of our already analyzed whole genomes of >100 CMS and non-CMS subjects as well as other
molecular and genomic tools to better understand the role of SENP1 in hypoxia and understand the
mechanistic basis of protection in females. Based on our preliminary results, we have formulated the central
hypothesis that the hypoxia-induced polycythemia of high altitude has a genetic basis and that SENP1
plays a critical role in this extreme trait of polycythemia in Monge's disease. Our Specific Aims are:
Specific Aim 1: Elucidate the role of SENP1 single nucleotide polymorphisms (SNPs) in
regulating the marked hypoxia-induced polycythemia in CMS and the lack thereof in non-CMS
subjects. We hypothesize that specific SNPs regulate SENP1 up-regulation in CMS but not in non-CMS in
response to hypoxia.
Specific Aim 2: Determine the transcriptomic changes and pathways that play an important role
in the hypoxia-induced polycythemia in CMS. We hypothesize that an up-regulation of SENP1 will induce
specific transcriptional changes in CMS cells that lead to the CMS polycythemic phenotype.
Specific Aim 3: Investigate the role of hormonal factors in the gender-dependent high altitude
induced excessive erythropoiesis. We hypothesize that the effect of estrogen hormone on SENP1/GATA1 is
responsible for protection of females from CMS polycythemia.

Public health relevance
Project Narrative We are interested in finding the reasons why some individuals make too many red blood cells (RBC, polycythemia) at high altitude and others do not when they sojourn at high elevations. The individuals who make a lot of RBCs can die early in adulthood because of the concentration of red blood cells in the blood and the danger that this increased RBC can lead to stroke or myocardial infarction. Another interesting observation is that females, by and large, are protected from this disease until after menopause. Since we have sequenced the genomes of such individuals, we have information that will enable us to determine the basis for polycythemia. Although we seem to focus on high altitude diseases, our research efforts will also give us clues for similar diseases at sea level.